Gatan K3 Direct Electron Detector Model 1967

Project Summary/Abstract
This request is for a large-field-of-view direct electron detector with high quantum efficiency to enable in situ cryo-
electron tomography and high-resolution single-particle cryo-electron microscopy at the Rutgers CryoEM &
Nanoimaging Facility (RCNF). This detector will at least treble data throughput, which is enables us to solve series of
related structures for mechanistic insights (for instance, transcription/translation coupling complexes bridged by RfaH
that differ in the length of RNA between the polymerase and ribosome). The high throughput plus the increased signal
will allow us to solve more heterogeneous and flexible structures such as the destabilized nucleosome in complex with
Nucleosome Destabilizing Factor. The large field of view will be key for in situ tomography of [], of
transcription/translation coupling inside E. coli minicells, and of understanding how gene therapy vectors deliver
therapeutic DNA. The electron detector will be mounted on our existing cryo-transmission electron microscope and
operated as part of a university core facility with training, support, and consultation from the expert RCNF staff
members available to intramural and extramural investigators. The RCNF operates on a university-subsidized recharge
basis and there is institutional commitment to maintain and service the equipment.

Public health relevance
Narrative This electron detector will be used to see the atoms in proteins, DNA, and RNA in order to understand antimicrobials, transcription, transformation, and viral gene therapy. Moreover, the large field of view of the detector will enable us to image inside cells at the nanoscale. The detector will treble the amount of data collected by our electron microscope while improving resolution.